The molecular circuits controlling human T follicular regulatory cell development

PROJECT ABSTRACT
GC responses are steered toward pathogen-recognition and away from self-reactivity by T follicular
regulatory (Tfr) cells. The molecular means by which Tfr cells exercise control are unknown. GCs are
deranged and Tfr subsets are altered in lymph nodes excised from common variable immunodeficiency
(CVID) patients. CVID is a genetic disease caused by mutations in immune critical genes like CTLA4, NFKB1,
PIK3CD or PIK3R1 and diagnosed based upon poor vaccine responses and a proclivity for autoantibody
production. The relevance of Tfr cell defects to CVID pathogenesis is unclear. The long-range goal of the
proposed work is to determine how GCs are controlled in health and how governance loss promotes immune
deficiencies and autoimmune diseases. The objective of this grant application is to establish which lineage
lymph node Tfr cells belong to in humans and how lineage-specific Tfr cell developmental aberrations
contribute to autoimmune pathologies. The working hypothesis is that the Tfr cell pool encompasses both
“natural” nTfr cells that descended from Tregs and iTfr cells that are induced from T follicular helper (Tfh)
cells. Whereas nTfrs express autoreactive T-cell receptors and enforce self-tolerance, iTfrs arrive weeks into
a GC response to amplify affinity maturation and ultimately quinch the reaction. Based upon altered
circulating iTfr to nTfr ratios in CVID patients, we anticipate counterpart cells in their paired lymph nodes will
display altered frequencies, locations and repertoires. Our rationale is that by understanding which GC
response elements are controlled by iTfrs and nTfrs, we can develop new diagnostic and therapeutic
opportunities for patients with GC-dysfunction disease including, but not limited to, CVID. Our specific aims
will test the following hypotheses: Aim 1: iTfr and nTfr cells can be clonally distinguished and functionally
described in lymph nodes and blood from controls and CVID patients Aim 2: iTfr and nTfr cells can be
localized within healthy and CVID lymph node sections and Aim 3: CVID Tfr defects and CVID-associated
GC dysregulation can be reproduced in genetically edits tonsil organoids. The contribution is significant
because the molecular underpinnings of human GC regulation are unknown are of great consequence to
patients with autoimmune and immunodeficiency diseases. The proposed work is innovative because we
propose defining protein and gene expression of single human cells in their native, tissue-resident spatial
context with a suite of modern, high-dimensional technologies uniquely suited to our topic. Further, we are
verifying our findings in rare excisional lymph node biopsies of CVID patients using high-dimensional imaging
and disease modeling in genetically edited tonsil organoids.

Public health relevance
PROJECT NARRITIVE: Common variable immune deficiency (CVID) patients are susceptible to infectious and/or autoimmune diseases because their lymph nodes cannot generate the right types of antibodies. The reasons for CVID lymph node dysfunction are unknown, in part, because we do not understand how healthy lymph nodes chose which antibodies to produce. By determining which lymph node cells regulate antibody production, how they exercise control and where they come from, we can better understand why lymph nodes malfunction and we can develop better targeted therapies to restore balance in patients with autoimmune and immune deficiency diseases.